Nanoscale cryo-electron tomographic analysis of nucleosome condensates in neuronal chromatin

Abstract
In mature neuronal cells, global chromatin condensation and heterochromatin spreading are associated with an
increased susceptibility to cell death and tissue degeneration and decreased potential of re-entering the cell
cycle for either healthy regeneration or malignant transformation. Heterochromatin condensation has been
proposed to be mediated by expansion of nucleosome condensates through a process called liquid–liquid phase
separation (LLPS). Still, the molecular mechanism(s) responsible for the massive chromatin condensation and
its reversal remain unknown and the liquid or solid nature of the nucleosome condensates is disputable and
depends on specific experimental conditions. We found that certain epigenetic modifiers that inhibit
heterochromatin condensation can restore retina layers and partially reverse blindness in a mouse model of a
retina degeneration disorder, retinitis pigmentosa. Here we propose to study mechanism of heterochromatin
condensation and de-condensation using a novel approach: resolving the structure of nucleosome condensates
in heterochromatin using cryo-electron tomography (cryo-ET). Our main hypothesis is that the nucleosome
condensates contain the inner “molten core” with randomly positioned liquid-like nucleosomes and the solid
“outer shell” with nucleosomes juxtaposed at short distances into partially interdigitated zigzag stacks. Histone
posttranslational charge modifications (such as acetylation) play a major role in destabilizing the nucleosome
stacking so that certain clusters of un-stacked nucleosomes would unfold and open their nucleosome interfaces
to accommodate transcriptional activation factors and reduce the repressive heterochromatin compartments.
To test this hypothesis, we propose two specific aims:
In SA1, we will isolate chromatin from retina rod photoreceptors and cerebellum granule cells from
control mice and those treated by HDAC1 and LSD1 inhibitors. We will determine efficiency of nucleosome
condensation, the associated charge of control and modified histones and study what set of genes are
condensed during rod photoreceptors development, and what particular histone modifications and non-histone
proteins (if any) discriminate between the condensed and the soluble phases. In SA2, we will use cryo-ET of
the isolated nucleosome condensates and of vitrified retina rod photoreceptors and cultured cerebellum granule
cells samples in situ to determine individual nucleosome positions, center-to-center distances, axial angles, and
plane angles in 3D space. These experiments are expected to provide mechanistic insights for the chromatin
condensation in mature neuronal cells and its inhibition by epigenetic modifiers that may lead to a more efficient
treatment of retinitis pigmentosa and other neurodegenerative disorders and develop new tools for imaging of
nucleosome condensates in the cell nucleus.

Public health relevance
Project Narrative Certain neurogenerative disorders such as retinitis pigmentosa and spinocerebellar ataxia 7 that are caused by mutations of genes that are active in fully mature neuronal cells with abundant nucleosome condensates. Such disorders can be partially treated by epigenetic drugs that inhibit nucleosome condensation and reduce cell maturation to prevent tissue degeneration. This project will examine the mechanism of nucleosome condensate formation and its reversal by epigenetic drugs that will lead to new or improved epigenetic therapies for neurodegenerative disorders affecting mature neuronal tissues.